Mechanistic probes to study the immune response in periodontal disease

Abstract
Periodontal diseases affect 42% of adult Americans and are characterized by bacterial-driven inflammatory
bone loss. Traditional and emerging treatments for periodontitis management do not typically target the host
immune response, which is the major source of tissue damage. The demethylation activity of the chromatin
remodeling enzyme lysine-specific demethylase 1 (KDM1A) at the transcription activating mark histone 3 lysine
4 (H3K4) leads to a decrease in pro-inflammatory cytokine transcription. By contrast, the chromatin remodeling
enzyme lysine specific demethylase 4B (KDM4B) specifically demethylates the transcription deactivating mark
histone 3 trimethyllysine 9 (H3K9me3), leading to up regulated expression of pro-inflammatory cytokines
(PICs). Interestingly, cross talk between these two enzymes leads to a balanced system wherein lysine 9
hypomethylation by KDM4B serves as a prerequisite to lysine 4 hypomethylation by KDM1A. The research
plan outlined in this proposal will exploit this crosstalk for the design of new chemical probes for use in the
study of the epigenetic basis for PD. The the central hypothesis of this study is that promotion of KDM1A
activity by introduction of a specific KDM4B or KDM4E inhibitor will alleviate PD by reducing the expression of
PICs in diseased tissue and reducing osteoclast formation. Inhibitors so identified will be useful as chemical
probes to study the biochemical basis of inflammation and bone loss in PD. We will test this hypothesis
through completion of the following Specific Aims: Specific Aim 1: We will use structure-based design
techniques to discover novel inhibitors of KDM4B or 4E for use as chemical tools to elucidate the mechanism
underlying inflammation and bone loss in PD; Specific Aim 2: We will define the cellular mechanism by which
KDM4B/4E over expression contributes to periodontal inflammation and bone loss; Specific Aim 3: We will
evaluate novel and known KDM4B/4E inhibitors for immunomodulatory activity in vivo using two models of PD.
Our preliminary results demonstrate that KDM4B and 4E protein is more abundant in vivo in periodontally
diseased connective tissue, and that inhibition of KDM4B results in significant decreases in PIC production and
osteoclastogenesis in tissue pre-treated with a periopathogenic lipopolysaccharide. New and existing inhibitors
will be used to further validate KDM4B as a therapeutic target in PD, and computational chemistry docking
experiments paired with physical compound screens will be employed to correlate compound structure and
changes in disease progression markers. Selected KDM4B inhibitors will be interrogated both in vitro and in
vivo for efficacy and toxicity. This study will provide a more robust understanding of epigenetic mechanisms
that play a significant role periodontal disease progression, validate KDM4B as a drug target for periodontitis,
and result in development of chemical probes with therapeutic potential for local immunomodulatory adjuvant
treatment of PD. This project will break down barriers between the fields of periodontics and drug design and
will foster the development of knowledge on a critically needed aspect of translational oral health science.

Public health relevance
Project Narrative Periodontal disease affects 42% of adult Americans, yet there are no effective adjunctive treatment options following traditional non-surgical or surgical intervention. To date, the epigenetic mechanisms that govern periodontal health and disease are not well defined. The research outlined in this proposal will identify major epigenetic mechanisms engaged in periodontal disease progression and target these processes for the design of novel chemical probes and therapeutic agents.